Core 3: Biostatistics and Bioinformatics Core

PROJECT SUMMARY – CORE 3
The principal objective of the Biostatistics and Bioinformatics Core (Core 3) is to provide project investigators a
centralized resource for biostatistics and bioinformatics expertise. Statistical issues will be addressed at all
levels of investigation: from the design of experiments to the maintenance of data quality; and from conclusions
based on formal hypothesis testing, to important leads discovered by thorough data exploration. The specific
aims of the Core are: 1.1. Collaborate with project investigators in the formulation of unambiguous
hypotheses and hypothesis testing strategies, and in the design of experiments. Biostatistics
collaboration will assist researchers at the design stage by: formulating biological and clinical questions as
testable statistical hypotheses; devising efficient experimental designs and matching these with appropriate
statistical models for both basic and high dimensional informatics data; determining sample sizes necessary to
ensure high power; and strongly controlling type I error. 1.2. Provide support for all projects with: formal
hypothesis tests in experimental and clinical data that ensure strong conclusions; exploratory
bioinformatics analyses that lead to further experiments, refined hypotheses, or discoveries; statistical
modeling and sensitivity analyses of complex data; and visual displays of data that clarify conclusions
and uncover leads. Core 3 statisticians/informaticians have worked extensively with investigators to develop
comprehensive analysis plans that distinguish between formal testing (which provides evidence for strong
conclusions) and exploratory bioinformatics analyses (which do not allow for strong conclusions but lay the
groundwork for important discoveries). Core statisticians/informaticians will employ the most robust methods
for modeling and sensitivity analyses to ensure reliability of results. For all data, visual displays will be
emphasized to reveal the reliability of conclusions and aid in the discovery of new leads. 1.3. Provide data
management and integration services that ensure high integrity, security and investigator
accessibility. Ensure statistical and informatics analysis consistency and transparency across
projects, and have a centralized repository of all analysis procedures and results. To promote data
integration across projects, Core 3 will have a centralized repository of all data that is secure and accessible to
the investigators. Data will be cleaned, merged and de-identified. All missing and outlying data will be reported
to investigators. Core 3 will ensure consistency of analysis plans and reports for the same data types across
projects. 1.4. Conduct innovative statistical and bioinformatics modeling to directly combat complex
data or design problems that arise in projects and where current methods do not apply. When faced
with specific issues that arise in these projects where current analysis methods do not apply, Core 3 personnel
will either adjust available methods or develop novel procedures to address the problems.

Public health relevance
PROJECT NARRATIVE – CORE 3 The Biostatistics and Bioinformatics Core will provide critical support for planning and design of experiments and studies, statistical and bioinformatical analyses and display of data, and data management and integrity. This support is designed to ensure that studies yield reliable conclusions, resources are efficiently used, and exploratory analyses uncover important leads.